NICHD - REPRODUCTIVE TOXICOLOGY

The purpose of this contract is to provide Program with consulting services (e.g., opinions related to reproductive toxicity experiments) for the betterment of a given contraceptive research program. These services are responsive to an identified need by the Contraception Research Branch (CRB) and are used to make informed decisions on identified funded research (e.g., grants and/or contracts). Current staff in CRB do not possess the prerequisite skill set to provide a response on such matters. Provided services